Therapeutic Targets for Chronic Allograft Rejection

DESCRIPTION (provided by applicant): Chronic rejection (CR) is the leading cause of late allograft loss, and is prevalent in cardiac, lung, renal, and to a lesser degree, liver transplantation. CR is a progressive, irreversible disease that is characterized by deteriorating graft function, interstitial fibrosis, and the formation of occlusive neointima, referred to herein as transplant associated vasculopathy (TAV). We have reported that CR in mouse cardiac allografts is also associated with cardiomyocyte hypertrophy. This has clinical relevance in that cardiac allograft hypertrophy has recently been identified as a prognostic marker for TAV, heart failure, and increased patient mortality following transplantation. Hence, interstitial fibrosis, TAV, and cardiac hypertrophy are manifestations of CR. Despite intense investigation, the etiology of CR and associated pathologies are very poorly understood. Hence, reliable therapeutic targets for the prevention and treatment of CR have not been identified and no effective therapies exist except re-transplantation. Due to its profibrotic activities, TGFβ stands out as the cytokine most implicated in CR. However, there are many immunosuppressive activities of TGFβ which are considered beneficial in the transplant setting. Indeed, we have reported a critical role for TGFβ in suppressing graft-reactive T and B cell responses in mice that accept cardiac allografts following transient depletion of CD4+ cells. What is not known is how TGFβ contributes to CR and whether fibrosis inducing elements downstream of TGFβ may be targeted as therapies for CR. The overall hypothesis for this proposal is that profibrotic activities of TGFβ may be selectively targeted as a therapy for CR while sparing the beneficial immunosuppressive qualities of TGFβ which promote graft acceptance. We have recently identified IL-6, connective tissue growth factor (CTGF), and IL-17 as mediators of CR which lie downstream of TGFβ and may serve as therapeutic targets for CR. We will test this possibility and will elucidate the interactions of TGFβ, IL- 6, CTGF, and IL-17 in promoting CR. The individual and synergistic contributions of these cytokines to fibrosis, TAV, and hypertrophy will be elucidated and their hierarchy as therapeutic targets will be identified. These studies will be performed in the mouse cardiac allograft model where transient depletion of CD4+ cells prolongs graft survival yet all manifestations of CR develop. Aim 1 will test the role of recipient vs. graft derived IL-6 in CR and will determine whether targeting the IL-6 trans-signaling pathway will ablate the CR inducing effects of IL-6 on the graft, but spare the protective effects of IL-6 required for productive immune responses. Since CTGF and IL-17 both lie downstream of TGFβ and IL-6, Aim 2 will elucidate the individual and cooperative roles for CTGF and IL-17 in CR and determine the effectiveness of targeting these cytokines in tandem. Aim 3 will test the hypothesis that CD4+ cells are critical for the induction of CR, but the progression of the disease may be prevented by targeting IL-6, CTGF, and/or IL-17. These studies will provide mechanistic insight for the development of novel therapies for preventing the induction and progression of CR. PUBLIC HEALTH RELEVANCE: While transplantation is the treatment of choice for end-stage organ disease, chronic allograft rejection is the main barrier to long term graft acceptance. The cause of chronic rejection is not well understood and there are currently no effective treatments for this disease except re-transplantation. The proposed studies are aimed at elucidating the underlying mediators of chronic rejection with the goal of identifying new therapeutic targets for the treatment of this disease.

Public health relevance
While transplantation is the treatment of choice for end-stage organ disease, chronic allograft rejection is the main barrier to long term graft acceptance. The cause of chronic rejection is not well understood and there are currently no effective treatments for this disease except re-transplantation. The proposed studies are aimed at elucidating the underlying mediators of chronic rejection with the goal of identifying new therapeutic targets for the treatment of this disease.